Towards high-resolution structural biology of membrane protein complexes in their native lipid environment

(1) Structure and function of magnesium channel Mrs2
Mrs2 is the eukaryotic homolog of bacterial magnesium channel CorA. CorA forms a homo-pentameric channel which forms a symmetric closed state at normal to high concentrations of magnesium with magnesium binding sites between protomers as well as near the membrane pore. Under low magnesium concentrations the channel undergoes an asymmetric opening likely caused by the destabilization of protomer interactions when magnesium ions dissociate from their binding site. Together with postdoc Dr. Louis Tung Faat Lai we expanded our research on magnesium channels by looking at eukaryotic magnesium channel Mrs2 which is located in the inner mitochondrial membrane. We have solved high-resolution cryo-EM structures of in detergent purified human Mrs2 in different conditions and found that it also forms a home-pentameric complex but it shows significant differences to its bacterial homolog CorA. A 70-amino acid long mitochondrial transit peptide is cleaved off of the N-terminal domain of human Mrs2 upon translocation into the mitochondrial membrane. Magnesium binding sites along the pore of the channel as well as in between subunits were identified, some of which may play a role in regulating channel activity. Two pore gates as well as an important inter-subunit salt bridge were identified, that when mutated lead to increased channel activity. Additional structural and functional studies of wild-type and mutant Mrs2 in synthetic as well as native nanodiscs as well as liposomes are planned to further investigate the structure, mechanism and regulation of this eukaryotic channel in its native lipid environment.

(2) Structural determination of full-length SARS-CoV-2 spike protein and drug development
COVID-19 caused by the SARS-CoV-2 virus has posed a global threat since it was first identified end of 2019. The rapid development of vaccines helped to counteract the rapid spread of COVID-19.
The SARS-Cov-2 spike protein is responsible for the initial binding of the virus to the receptor ACE2 on human cells. Better understanding of the function and structure of the spike protein is critical for development of both primary prevention such as vaccine, and therapeutic treatments to combat the COVID-19 pandemic. Structures of the spike proteins soluble ectodomain have been determined but the full-length spike including its membrane domain has not been well studied. We are working towards determining the structures of full-length spike protein and identify the key vaccine and drug binding interfaces in order to develop treatments that block viral entry into human cells with high efficiency and specificity which are also safe for children. We have successfully cloned and expressed the full-length spike protein, and we are working towards high-resolution structural determination of different variants and complexes.

(3) Structural investigation of inner mitochondrial membrane supercomplex II and III
As the powerhouses of cells, mitochondria provide energy in form of ATP for most of the cellular activities. There are five essential protein complexes located on the inner mitochondrial membrane which carry out one of the most important reaction in the cells oxidative phosphorylation, which generates ATP. Functions of these protein complexes have been extensively studied and crystal structures of individual complexes have been determined. It is proposed that protein complexes of the respiratory chain can associate and form of supercomplexes or respirasomes. Among these five protein complexes, cytochrome bc1, also known as complex III, is a central component of the cellular respiratory chain. It catalyzes electron transfer from quinol to cytochrome c and couples this electron transfer process to proton translocation across the membrane. Mitochondrial Complex II, also called succinate dehydrogenase, is another important protein complex within the mitochondrial electron transfer chain. It oxidizes succinate from the Krebs-cycle to fumarate and reduces ubiquinone to ubiquinol. Previous studies have proposed the formation of a supercomplex between complex II and complex III, which has been confirmed by biochemical analyses of scientist Dr. Fei Zhou. We are currently working towards solving the structure of this supercomplex by Single-Particle Cryo-EM. Together with biochemical data, the structure of supercompex II and III will reveal detailed information of electron transfer between the Krebs-cycle and the respiratory chain and could shed light on the biogenesis and treatment of many human diseases related to respiratory chain deficiency such as delayed child development, autism, tumorigenesis and aging.

(4) Collaborations
Collaborations involving structural and computational studies on a variety of membrane proteins including transporters, channels, and receptors as well as viral spike protein conformations in different cellular compartments, virus-like-particle (VLP), SARS-CoV-2 accessory membrane protein, extracellular vesicles and lipid transport across cells, as well as testing new detergents and polymers to gently extract membrane protein complexes from their native lipid environment for high-resolution structural studies.